KLF14 and Cardiovascular Disease

Abdominal aortic aneurysm (AAA) is an asymptomatic disease of high mortality rate (65% to 85%) if rupture
occurs. Surgical repair is the only effective treatment, but limited to eligible patients (about 10% of total). No
effective pharmacological approach has been identified to limit AAA progression and rupture. Male sex is an
important risk factor for AAA, with about 4-6:1 male to female prevalence ratio. The reasons for this sex
disparity are unknown, but the delayed onset of AAA in women suggests that estrogen and its receptors (ERs)
may play a role in reducing the prevalence of AAA. Administration of estrogen has protective effects in AAA
animal models through reduction of pro-inflammatory mediators and the proteolytic pathway. However, long-
term estrogen therapy cannot be widely applied to treat AAA patients due to undesirable side-effects. Human
genetic studies uncovered that Kruppel-like factor 14 (KLF14) is robustly associated with chronic metabolic
diseases with a sex difference. We previously reported the biological function of KLF14 and its activator,
perhexiline, clinically used to treat angina and heart failure, in lipid metabolism and demonstrate the strong
anti-inflammatory effect of KLF14. Our preliminary data described herein established that macrophage-
selective Klf14 knockout mice showed significantly increased AAA incidence rates in females, comparable to
those in males, suggesting impaired protective effects of estrogen/ERα/β pathway. Besides the inhibitory
effects of KLF14 on the inflammatory response and MMP-9 activity, we further found that estrogen upregulates
the expression of KLF14 while KLF14, in turn, is a critical transcription factor upregulating the expression of
ERα/β in macrophages, uncovering a feedforward loop that may contribute to the observed sex disparity.
Perhexiline increased the levels of ERα/β in a KLF14-dependent manner. A cholesterol metabolite, 24-
hydroxycholesterol (24HC), functioned as an endogenous ERα/β agonistic molecule and enhanced the anti-
inflammatory effect of perhexiline in macrophages. Most importantly, administration of perhexiline significantly
reduced AAA dissection/rupture and increased survival rate in male mice. Based on our preliminary findings,
the proposed project will test the central hypothesis that KLF14 protects against AAA development/dissection
/rupture by suppressing inflammation and enhancing ERα/β-dependent protective roles in macrophages. The
specific aims will 1) define that macrophage KLF14 is an important regulator of sex differences in AAA mouse
models; 2) determine how KLF14 regulates the estrogen/ERs pathway which contributes to sex-dimorphic
protective effects on AAA; and 3) determine that activation of KLF14 inhibits development/dissection/rupture in
AAA mouse models. Based on the sex-specific functions of KLF14 in AAA, this mechanistic research will
establish KLF14 as a novel therapeutic target and will set a solid foundation towards clinical utilization of
KLF14 activators, like perhexiline, as a viable drug therapy for AAA, with the potential to change current
treatment paradigms for AAA.

Public health relevance
PROJECT NARRATIVE Abdominal aortic aneurysm (AAA) is a life-threatening condition in adults, especially in male individuals, because estrogen and estrogen receptors have protective roles against AAA in females. A new mechanism was identified by which a factor, KLF14, inhibits inflammation and increases estrogen receptors in macrophages. The information generated from this study will promote the development of more effective drug therapies for the prevention of rupture or to promote reversion of AAA, which currently are not available.